In vivo vascular delivery of an MK2 inhibitory peptide for the prevention of smooth muscle cell phenotype switch and intimal hyperplasia.

PROJECT SUMMARY
Peripheral artery disease (PAD), an atherosclerotic disease leading to peripheral artery obstruction,
affects over 6.5 million people in the US. PAD reduces blood flow, causing limb pain, non-healing wounds, and
in extreme cases even death. Percutaneous transluminal angioplasty (PTA), involving inflation of a balloon at
the site of blockage to re-open the arterial lumen, is a common treatment for PAD. However, vascular wall stress
associated with balloon distension (sometimes in combination with stent placement) damages and activates
stress response in the tissue, leading to restenosis, a re-narrowing of the artery. Because of these complications,
most PTA-treated vessels fail within the first 12 months. Restenosis is driven by the pathological process intimal
hyperplasia (IH), characterized by vascular smooth muscle cells (VSMCs) switching from a contractile to
synthetic phenotype, causing them to become more migratory, proliferative, and active in secreting extracellular
matrix (ECM) and inflammatory cytokines. Synthetic VSMC activities produce neointima that closes back off the
vessel and that serves as a fertile ground for advanced atherosclerosis or even thrombosis. Current therapeutic
strategies to reduce IH focus solely on inhibiting VSMC proliferation through the use of drug coated balloons and
stents. However, these methods have not shown promise in improving vessel patency in clinical trials. I have
been pursuing inhibition of the p38-MK2 “stress response” signaling pathway as a more comprehensive IH
therapy that targets the underlying mechanisms that drive the pathological VSMC phenotype switch. In my recent
studies, inhibition of MK2 through the use of a novel peptide therapeutic (MK2i) electrostatically complexed with
a pH-sensitive endosomolytic polymer to form nanopolyplexes (MK2i-NPs) proved to be promising in the
inhibition of VSMC proliferation, phenotype switching, and IH. In the context of vascular bypass grafts, a rabbit
vascular transplant model showed that a single intra-operative treatment with MK2i-NPs (topically to explanted
tissue) inhibited neointima formation up to 28 days after surgery and mitigated VSMC phenotype switching during
the acute (7 day) stress response phase post-transplant. We hypothesize that in vivo, catheter-based delivery
of MK2i in conjunction with balloon angioplasty will prevent VSMC phenotype switching and protect against
restenosis and vessel failure. To model in vivo delivery from a specialized catheter, I will develop an ex vivo
bioreactor system and apply this system to evaluate the effects of pressure on MK2i penetration and retention
in the vessel wall. Additionally, we will use the bioreactor to evaluate pharmacokinetics and pharmacodynamics
of MK2i in arteries ex vivo. Finally, based on the pressure conditions optimized in initial work, we will apply a
specialized occlusion perfusion catheter to create a “chamber” within the lumen of the vessel through which the
MK2i-NPs can be controllably administered for convective transfer into the vascular wall in vivo. This system will
be deployed in a pig model to assess the effect of in vivo MK2i delivery on maintenance of VSMC contractile
phenotype and overall vessel patency following PTA.

Public health relevance
PROJECT NARRATIVE Peripheral artery disease (PAD) affects an increasing number of people in the U.S., and current therapies like balloon angioplasty require additional intervention in half of patients within a year due to restenosis. Our previous data identified MK2 as a druggable target for blocking post-procedural vascular restenosis in vein graft transplant. This proposal aims to develop and test an in vivo delivery method for an MK2 inhibitory peptide to the site of PAD after angioplasty to prevent restenosis and vessel failure.